INTERNAL AND EXTERNAL COMMUNICATIONS AND DISSEMINATION SUPPORT FOR DCCPS

The Contractor shall provide engagement and outreach support to internal and external audiences to help set and refine research agendas, improve awareness of NCI research and availability of NCI-developed tools to support research efforts by grantees and other partners; reach target audiences through partnerships, as well as earned, paid, and other outreach efforts; measure the impact of these efforts and provide analysis and insights that may be used in similar future efforts.